Understanding addiction vulnerability genes

Addiction vulnerability genes include those that are likely to harbor allelic variants that contribute to human individual differences in vulnerability to addictions. During this and prior years, we identified more than 100 such genes based on the covergences between nominally-positive data derived from up to ten separate abuser/control comparisons. Interestingly, during the current year we have found the most support from outside samples/datasets for the genes that we have identified most consistently in our own data. We added to evidence supporting roles for many of these genes with additional data from several comparisons between nicotine depdendent and control samples and substance dependent and control samples with higher marker densities. We added additional support from comparisons between smokers who were successful vs unsuccessful in quitting in clinical trials and in community samples. Genes identified in this fashion include a disproportionate number of genes whose products are involved in cell adhesion molecule actions. During this year we identified another functional variation at a locus that contain these genes, focusing on a haplotype that alters level of expression for CDH13.